Investigation of Urethral Dysfunction in Female Urinary Incontinence

Project Summary
This proposal outlines a detailed training plan for the surgeon-scientist candidate to become an independent
investigator. The proposal highlights the candidate’s research and career development plans to study female
urethral aging and urinary incontinence (UI). UI is highly prevalent in women, rises with age, and costs~$10
billion annually. The current UI treatments leave up to 57% of the treated females with incontinence. Urethral
failure is a key cause of UI, yet it is not addressed in any current UI treatments. Urethral function declines 15%
per decade with aging. As such, this research aims to address the current knowledge gaps by unraveling the
molecular changes in aging female urethral striated muscle and then translating the findings into potential
treatments for urethral dysfunction. The candidate’s recent publication examined the impact of aging on the
mouse urethra and found aged mice, like elderly females, exhibited notably reduced functional leak point
pressure, significant loss of striated muscle and elastin, and increased fibrotic connective tissue compared to
young mice. Gene expression profiling revealed the upregulation of extracellular matrix remodeling (e.g.,
Adamt5) and fibrogenic (e.g., Ctgf) genes in aged urethral tissues. Immunofluorescence staining and
RNAscope analysis displayed an increased population of Pdgfrα+/Ly6a+ fibro-adipogenic progenitors (FAPs)
cells expressing Ctgf in the striated muscle layer of aged mouse urethra compared to its younger counterparts.
These findings suggest a novel mechanistic hypothesis that aged urethral tissue striated muscle dysfunction
is attributed to increased fibrosis due to altered FAP cells that secrete factors, such as Ctgf, and that
targeting Ctgf may result in the improvement of urethra function. To determine these mechanisms, the
candidate will conduct a mouse and human urethra study (Aim 1) to identify changes in the transcriptome of
FAP cells across three life stages of the female urethra. The proposed research also aims to determine the
impact of Ctgf in age-related fibrotic urethral muscle dysfunction (Aim 2).
This work will result in a deeper understanding of age-related urethral tissue dysfunction, and the potential to
inform translation into the clinical setting. Through a rigorous mentorship and didactic plan, the candidate will 1)
gain skills in analyzing and interpreting next-generation sequencing data (Aim 1) and 2) develop a genetically
modified mouse model for understanding urethral failure (Aim 2), and ultimately evaluate potential drug
treatments for UI (future). The candidate has assembled a robust and multi-disciplinary mentor team,
developed a well-defined career development plan, and is provided phenomenal support from the UCI
Department of Urology and the UCI Physician-Scientist Training program. This support and the rigorous
training plan will ensure the PI achieves the proposed scientific goals proposed and is well-prepared for a
successful, independent research career in investigating urinary tract dysfunction and UI.

Public health relevance
Project Narrative Urinary incontinence affects up to 60% of women and rises with age, costing nearly $10 billion annually and significantly reducing quality of life. Current treatments often leave many women with persistent or recurrent symptoms, and do not address urethral dysfunction, highlighting the urgent need for deeper understanding and novel therapies. This research aims to elucidate the cellular and tissue-level mechanisms underlying urethral dysfunction accompanying aging, paving the way for more effective treatments and improved outcomes for affected women.